Characterization and targeting of rapid nucleotide exchange RAS mutations

RAS mutations drive a large proportion of deadly human tumors but no targeted therapies have
advanced to clinic. We and others have shown that certain oncogenic RAS mutations have unique
biochemical properties and have shown that functional classes of RAS mutations are differentially regulated,
opening the door to RAS allele-tailored treatment approaches. RAS allele-specific therapies have the potential
for rapid clinical translation and would be worthwhile because (1) RAS mutation status is already routinely
assessed in current clinical practice for multiple common cancers, (2) potent and selective small molecules
targeting members of RAS signaling pathways, or regulators of those members are already available, and (3)
RAS mutations occur frequently enough in cancer that a significant number of patients would benefit even
though therapies apply to subsets of RAS mutation-positive tumors. This proposal seeks to develop direct and
indirect therapeutic strategies based on the unique mode of activation and resultant signaling properties of
KRAS A146T and other RAS exchange mutants. This study has translational therapy implications given that
KRAS A146T is already screened for in clinical practice, but no targeted therapies currently exist.

Public health relevance
We aim to develop KRAS allele-specific cancer therapies by studying the contributions of specific KRAS mutations to cancer signaling and use that information to develop novel biomarker-driven treatment regimens. This grant will focus on KRAS codon 146 mutations, which have a unique mode of activation by enhanced nucleotide exchange. These mutations are found in colorectal cancer and liquid tumors.